Boosting Mentor Effectiveness iN Training of Research Scientists (MENTORS) Using Social Cognitive Career Theory to Support Entry of Women & Minorities into Physician-Scientist Careers

PROJECT SUMMARY
The workforce of physician scientists, particularly in positions of senior leadership, persistently fails to reflect
the diversity seen in both the general population and the diversity in US medical schools, with women and
minorities underrepresented in the physician-scientist pipeline. One potential mechanism to address this is the
presence of scholarly concentration programs (SCPs) within the traditional 4-year medical school curriculum.
SCPs allow MD-only degree candidates to participate in a mentored research projects in an effort to increase
interest in career-long research. SCP outcomes are often measured by increased publication rates or
increased intention for a research career from matriculation to graduation, which has been shown to predict
successful entry into a physician-scientist career. The Scholarly Concentrations Collaborative is a coalition of
10 medical schools actively conducting research on mentoring and promotion of scientific careers. Notably, the
Collaborative has undertaken multi-site research to study the predictors of increased intention to enter
research careers related to mentorship. While SCPs have primarily focused on program evaluation to date,
theoretical and mechanistic studies exploring the science of mentoring in SCPs are lacking. Social cognitive
career theory (SCCT) is one theoretical model that could explain successful mentoring of medical
students into future physician scientists. Several studies indicate that research self-efficacy is an important
predictors of entry into scientific careers. At University of Chicago, we found that research self-efficacy at
matriculation is associated with increased intent for career-long research when controlling for initial interest in
basic science, gender, and minority status. In a 2-site study of first year students at the University of Chicago
and the Icahn School of Medicine at Mount Sinai, we found that establishment of a strong mentoring
relationship is rated as the most important goal among medical students, and is valued more by female
students compared to male peers. Lastly, in a multi-site study of mentoring among graduates from 10
institutions, we found that although women and URM students are more likely to select mentors who are
gender- or minority-status concordant, mentor-student concordance is not associated with intention to enter a
research career or publication. Instead, we found that mentors who invested in the professional development
of their students (compared to those that invested in project completion) were rated most impactful on
students' intent for career-long research and students' professional identity. Based on our preliminary data, we
will conduct a randomized trial of 300 mentors of women and minority medical student mentees to test whether
a targeted intervention based on social cognitive career theory for mentors could lead to increased research
self-efficacy, research career persistence, and increased objective measures of research productivity among
their mentees. In addition to understanding whether such an intervention could succeed, it is equally important
to understand the underlying mechanisms for how and why a mentoring intervention based on SCCT
succeeds. We will specifically examine whether trainee engagement, as measured by Experience Sampling
Method in real-time, mediates the effects of the intervention on relevant research career outcomes.

Public health relevance
PROJECT NARRATIVE The workforce of physician scientists persistently fails to reflect the diversity seen in both the general population and the diversity in US medical schools, with women and minorities underrepresented in the physician-scientist pipeline. In this proposal, we will conduct a randomized trial to test whether a targeted intervention based on social cognitive career theory for mentors of women and minority medical students could lead to increased research self-efficacy, research career persistence, objective measures of research productivity and judgments of scientific potential among women and minority mentees. In addition, we will explore whether mentee engagement in research experiences, as measured by Experience Sampling Method (ESM) in real-time, is a mechanism by which the effects of the intervention are mediated.